Studying phenotypic states of antitumor human T cells

Following my recent appointment as a Stadtman tenure-track Investigator at the National Cancer Institute, Center for Cancer Research I am currently in the process of establishing my lab within the Surgery Branch. This includes acquiring key reagents and the necessary equipment and technology for carrying out my research and completing the required training. I am also taking steps to recruit several postdoctoral fellows, as well as post-baccalaureate fellows. I anticipate initiating research studies outlined in this project before the end of the fiscal year.